Repository Core

PROJECT SUMMARY – Repository Core
The overarching goal of the Clinical significance of INciDEntal white matter lEsions on MRI in a Diverse
population with cognitive complaints (INDEED) is to identify anatomic and biologic modulators of progressive
white matter (WM) injury that drive cognitive impairment using a precision medicine approach in a large and
diverse clinical population. To achieve this goal, three essential biological datasets will be acquired: 1)
harmonized neuroimaging data to document the degree, location, and amount of WM injury; 2) fluid biomarker
data to evaluate risk modifiers including inflammation, endothelial dysfunction, and co-morbid
neurodegenerative conditions; and 3) genetic data to measure intrinsic genetic susceptibility using polygenic
risk scores for Alzheimer's disease (AD) and WM hyperintensities (WMH) and known sequence variants (e.g.
APOE4 and NOTCH3). The goal of the Repository Core (RC), therefore, is to use harmonized approaches to
collect, process, store, track, analyze, and share neuroimaging, biospecimens and associated genetic data.
Centralized core services are needed to effectively support the research mission and enable the scientific
synergy necessary for a project of this scale, in which samples and data will be obtained from 2,250 diverse
subjects nationwide at three time points, for a total of up to 6,750 data/sample sets. Collecting data/samples
from multiple sites over 5 years will require standardized quality control (QC) checks, data tracking, and
coordination with research staff at participating clinic sites. The RC, with its leadership and investigators
experienced in managing similar tasks in the NINDS MarkVCID Consortium and ADRC Cores, will provide the
technical, professional, and physical infrastructure to effectively implement the core mission by executing four
specific aims. In Aim 1, the RC will work with NINDS, the Administrative Core (AC), and the collaborating clinic
sites to develop and implement standardized operating procedures for blood collection, processing, sub-
aliquoting, freezing, shipping, long-term storage, and distribution, by leveraging the existing AD Centers
Program, MarkVCID Consortium, and DISCOVERY Network protocols. In Aim 2, we will generate, store,
analyze, and distribute blood biomarker and genetic data relevant to WM injury and co-morbid
neurodegenerative pathologies. In Aim 3, we will oversee acquisition, analysis, QC, and distribution of
harmonized neuroimaging data that will directly inform the rate of progression and anatomic features of WM
injury to their role in cognitive impairment. In Aim 4, we will work with the AC and the Statistical Core to export
data and sample information, thus contributing to the sharing of data and specimens broadly with the research
community. The RC will ensure consistent integrity of data and samples that will deliver a high level of scientific
rigor and the reproducibility of results. The deposited data and biospecimens will create a rich and high-quality
resource for future analyses, novel biomarker discovery, and identification of therapeutically significant
pathways that underlie the contribution of WM injury to cognitive decline and dementia.